Investigating Fucosylation as a Mediator of Limbal Stem Cell Viability

ABSTRACT
Limbal stem cells (LSCs) are crucial for maintaining vision. Limbal Stem Cell Deficiency (LSCD) is a potentially
blinding condition caused by the death or dysfunction of LSCs. Pronounced local inflammation is a key
component of all LSCD etiologies, and recent work has emphasized a key role for Tumor Necrosis Factor
Alpha (TNF-α) in LSCD pathophysiology. LSCD has limited treatment options, generally necessitating
transplantation which has variable outcomes. To develop novel therapies a more thorough understanding of
factors that regulate LSC viability in inflammatory conditions is needed. Among these factors, the glycocalyx, a
diverse mixture of cell surface glycans, may significantly influence LSC survival. Fucose, a monosaccharide in
the glycocalyx, is abundant in mature, differentiated ocular surface cell types but is remarkably low in LSCs.
The relevance of low fucosylation to LSC biology is unknown. I have generated strong preliminary results that
suggest low fucose protects LSCs from inflammatory stress and cell death. My preliminary data indicate
that fucose synthesis increases in LSCs during inflammatory disease, potentially increasing LSC susceptibility
towards cell death. TNF-α receptor 1 (TNFR1), a conditional death receptor, is known to be fucosylated in
many cell types. Emerging evidence suggests the receptor relies on fucose modification for cell death
induction. Mechanistically, we hypothesize that low fucose in healthy LSCs renders TNFR1 and related
molecules inefficient as death receptors, thereby protecting this vital cell type from extrinsic cell death.
We will integrate these hypotheses and achieve the goals of this proposal by employing established in vitro
and in vivo models of fucose deficiency to assess LSC viability and corneal regeneration in human and mouse
limbal epithelial cells (Aim 1). Additionally, we will describe how fucose deficiency affects TNF-α:TNFR1
promoted death signaling in limbal epithelial cells (Aim 2). The proposed work will determine a role for fucose
in LSC viability and corneal wound healing. Additionally, it will shed light on the role of fucose on TNFR1
function. Successful completion of the proposal will result in knowledge that would enrich the current
understanding of LSC viability and the cornea’s regenerative function, potentially providing a valuable
foundation for developing novel therapeutics for LSCD and other ocular inflammatory diseases.

Public health relevance
PROJECT NARRATIVE This research addresses how low levels of the monosaccharide fucose in limbal stem cells (LSCs) effect their survival and function, especially during inflammation. The results will enhance our understanding of the role of the glycocalyx in cell survival and may lead to new treatments for Limbal Stem Cell Deficiency (LSCD) and other diseases.